Comprehensive food testing to prevent illness and combat chronic disease

SUMMARY: OVERALL PROJECT
The chronic disease epidemic and continuing exposure of Americans to harmful environmental toxins in
their foods constitute a public health crisis. The last line of defense for protecting Americans is food
testing for harmful chemicals and contaminating microbes that can cause life-threatening and life-long
complications. During the prior 5-year cooperative agreement with FDA, the Maryland Department of
Health (MDH) Laboratories Administration systematically built-up its food testing capabilities across
nearly the full spectrum of current and emerging threats. Through diligent investment in people and
resources, MDH Laboratories Administration has achieved major strategic advances that resulted in 18
harmful-product recalls, and most from imported foods. It now proposes to leverage these cutting-edge
capabilities to test foods for dangerous contaminants with two areas of focus. First, MDH Laboratories
Administration seeks to strengthen and expand its chemical testing of foods for known, and identification
of unknown, chemicals. Second, it seeks to offer its comprehensive across-the-board testing capabilities,
supported by its new direct electronic data connections for real-time reporting to FDA, to provide a low-
cost means to shift large-scale food testing from grocery store shelves to ports of entry and domestic
processing facilities. These state-of-the-art capabilities promise to ensure the safety of the food supply,
prevent illness, lower testing costs, and combat the chronic disease crisis.

Public health relevance
PROJECT NARRATIVE: Nearly two-thirds of American will develop chronic disease, and many through the prolonged ingestion of foods contaminated with environmental toxins, unapproved chemicals, and bacteria that can cause life- long complications. The last lines of defense are laboratories that can identify these threats and remove contaminated products, especially in imported foods, from the food supply. The Maryland public health laboratory has developed state-of-the-art capabilities, and now offers comprehensive food testing as a cost-effective way to protect Americans from a wide range of threats in their foods.